NCI PERSPCS AND SNEPCS DATA ANALYTIC AND PUBLICATION ACTIVITIES

Provide PERSPCS and SNEPCS policy data analytic activities, scientific writing contributions to publications linking the state Policy Classification Systems to other local and individual-level databases, and scientific opinion regarding dissemination of the policy classification systems data analytic results